PHARMACOKINETICS AND PHARMACOGENOMICS OF DOLUTEGRAVIR-BASED ANTIRETROVIRAL THERAPY IN YOUNG PEOPLE LIVING WITH HIV IN GHANA (PHARMA-YOUNG-HIV)

PROJECT SUMMARY
The World Health Organization (WHO) in 2019 recommended dolutegravir (DTG)-based antiretroviral therapy (ART) as the
preferred treatment regimen for all persons living with human immunodeficiency virus (HIV) in sub-Saharan Africa (SSA),
including children, adolescents, and young adults. Since then, most countries, including Ghana, have transitioned patients
from non-nucleoside reverse transcriptase-based antiretrovirals to DTG-based regimens. Despite the wide acceptability and
effectiveness of DTG, important side effects such as neural tube defects, hyperglycemia, obesity, and mood disorders are now
coming to the fore in several reports from SSA. In young people living with HIV (YPLWH) in Africa, the DTG switch was
done without a lot of studies. After the switch, the effectiveness (viral suppression) and adverse events have not been studied
in this population. According to the WHO, young people, defined as aged 10-24 years, are in a transition that poses risks to
their health and well-being. This population, even when fully adherent to medications, may be prone to suboptimal or
supratherapeutic drug concentrations, resulting in off-target effects, virologic failure, adverse drug events, drug-drug
interactions, and poor adherence. Therefore, there is an urgent need to study how this population metabolizes new drugs like
DTG that have been introduced into the ART regimen on a large scale.
We hypothesize that reduced or non-response to DTG-based ART is due to pharmacokinetic differences emanating from
pharmacogenetic variations, which cause adverse events without the benefits of viral control. We will test this hypothesis
with the following specific aims:
Aim 1: Determine rates of DTG-based ART resistance in young people living with HIV. We will determine which drug(s)
are responsible for virologic failure in YPLWH on DTG-based regimens. We will compare participants who are ART
experienced and naïve focusing on those with virologic failure on a DTG-based regimen and sequence protease, reverse
transcriptase and INSTI regions and identify mutations associated with drug resistance.
Aim 2: Determine the pharmacokinetic and pharmacogenomics variability of DTG-based ART and its influence on off-target
effects. First, we will use blood samples collected from ART-experienced and naïve young people at specific but different
time points following DTG-based ART administration to establish pharmacokinetic characteristics of patients using LC-
MS/MS to capture inter- and intra-individual variability. Second, we will use high throughput genotyping techniques, iPLEX,
PCR-RFLP, and TaqMan assays to analyze pharmacogenetic variations associated with phase I and II drug metabolism
(cytochrome P450 enzymes, UGTs), transporters, and target interactions.
Our study may help understand why some YPLWH develop resistance while on DTG or have off target effects on the
drug spurring further larger studies which may eventually help revise the one size fits all approach adopted for DTG-
based regimens in sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Majority of persons living with HIV are prescribed with fixed dosage formulations of dolutegravir (DTG)-based antiretroviral globally irrespective of predictors of therapeutic outcomes and undesirable effects such as drug resistance mutations, adverse drug events and virologic failure. Young people living with HIV (10-24 years) in Ghana are prescribed with DTG/3TC/TDF fixed dosage formulations with no assuring data from studies involving this age group. This study proposes to work to provide data on drug resistance mutations, pharmacogenetic variations and pharmacokinetic profiles that can affect the disposition and exposure of DTG/3TC/TDF in young people living with HIV in Ghana which can support dosage appropriate formulations for this age group.